Treatment strategies for ocular toxicity from chloropicrin

Project Summary
Chloropicrin (Trichloronitromethane, CP), currently used as a soil fumigant and pesticide, was employed during
World War I as a tear gas and choking agent and remains a potential agent for chemical terrorism. Its
exposure causes severe ocular injury, especially to the corneal tissue; however, mechanisms of its injury are
not well-defined and effective targeted treatments are elusive. The major goal of this application is to identify a
novel targeted therapeutic approach, which can effectively mitigate acute and long-term ocular injuries from CP
exposure, with a potential to be further tested against ocular injuries from other toxic chemical exposures.
Data from our studies in corneal epithelial cells and ex vivo rabbit cornea demonstrate increased levels of
nuclear erythroid 2-related factor 2 (Nrf2) and heme oxygenase-1 (HO-1), a critical target enzyme downstream
of Nrf2, suggesting that the Nrf2 pathway, a key antioxidant and cytoprotective system, could be activated
following CP exposure. Under this application, we propose to further asses the role of the Nrf2 pathway under
CP-induced ocular injury using Nrf2 knockout (KO) mice. Nrf2 activity triggers cellular protective mechanisms
against oxidative stress and inflammatory responses and is reported as a key target of new approaches for
treating various oxidative stress-related ocular diseases/injuries. Hence, employing Nrf2 activators may be a
novel approach for the treatment of ocular injuries due to CP exposure. Chemical ocular injury causes hypoxia
that leads to tissue damage; oxygen therapy is reported to improve tissue preservation and enhance wound
healing to mitigate ocular chemical and thermal burns. Our preliminary data shows the therapeutic potential of
supersaturated oxygen emulsion (SSOE) therapy in reversing CP-induced acute toxicity in HCE cells and ex
vivo rabbit corneas. Our hypothesis is that the Nrf2 signaling pathway is a key mediator in protecting against
CP-induced corneal injury; activation of the Nrf2 pathway can inhibit CP-induced oxidative stress and
inflammation, and simultaneous treatment with SSOE can increase tissue oxygen levels to improve tissue
preservation and enhance wound healing, leading to a novel and more effective treatment strategy against CP-
induced acute and long-term ocular injury. To test this hypothesis, the proposed aims are: Aim 1. To develop a
CP-induced ocular injury model in mice and determine if the Nrf2-ARE pathway is a key mediator in CP-
induced ocular injury using wild type and Nrf2 KO mice. Aim 2. To evaluate the efficacy of Nrf2 activators and
supersaturated oxygen emulsion alone, or in combination, to identify an effective therapeutic strategy against
CP-induced ocular injury. We anticipate that the outcomes from the above aims will establish a useful
mouse ocular injury model with CP and ascertain if the Nrf2 signaling pathway is a novel target for
therapeutic intervention to counteract CP-induced ocular injury. Successful completion of this project
will identify a novel therapeutic approach that can more effectively mitigate acute and chronic ocular
injuries from CP and lead to a better understanding of the mechanisms of CP-induced ocular toxicity.

Public health relevance
Project Narrative Chloropicrin (Trichloronitromethane, CP), currently used as a soil fumigant and pesticide, was employed during World War I and remains a potential agent for terrorism. Despite the devastating ocular injuries caused by CP, effective therapies to counteract the acute and long-term ocular toxicity remain elusive. Studies proposed under this application are anticipated to establish a useful mouse in vivo ocular injury model with CP and ascertain if the nuclear erythroid 2-related factor 2 (Nrf2) signaling pathway is a key mediator in CP-induced corneal oxidative stress and inflammation. Successful outcomes will identify a safe and effective treatment strategy that can improve efficacy and reduce CP-induced ocular toxicity using a Nrf2 activator treatment to target CP-induced oxidative stress and inflammation, and a supersaturated oxygen emulsion topical treatment to enhance tissue preservation and wound healing.